COMPUTER-BASED MONITORING OF THE CNS IN A CANINE MODEL

Evaluation of the integrity and function of the nervous system in critically ill patients who are comatose or who have some alteration of mental status currently cannot be done in an ongoing fashion. The purpose of this project is to develop and test a computer-based system for acquisition, analysis, and display of scalp-recorded neuroelectric signals (electroencephalogram and evoked potentials). This tool could be used to investigate the degree of dysfunction in neurologically impaired patients, to correlate the indices developed with other measures of cerebral function, and to evaluate the effectiveness of various therapeutic interventions. The system automatically sequences from one stimulus modality to the next while simultaneously adjusting preamplifier/filter parameters and saving the results for trend analysis. Programs for digital filtering, frequency domain analysis, and color displays for highlighting important trends have been implemented.